DeepTOBIDx: deep learning-enhanced multimodal diagnostic breast imaging

PROJECT SUMMARY / ABSTRACT
Imaging modalities routinely used in the diagnostic workup, i.e., mammography, ultrasound, and MRI, can catch
breast cancers at an early stage based on structural abnormalities but lack in providing physiological information
relevant to the function of tissue that determines tumor malignancy. Currently, the U.S. national benchmark of
positive predictive value for malignancy at biopsy after a BI-RADS 4 or 5 diagnostic assessment (PPV3) is only
30.4%. This means about 7 out of 10 biopsies come back negative for cancer. Prior research has demonstrated
that diffusion optical tomography (DOT), as a complementary functional imaging modality to clinical breast
imaging, bears ample potential for differentiating malignant and benign breast lesions to reduce unnecessary
biopsies. However, the clinical utility of DOT for breast cancer diagnosis is limited by two factors. First, due to
limited contrast recovery, conventional DOT has been primarily validated in patients with large masses, leaving
its ability to characterize smaller lesions often seen in the diagnostic population untested. Second, DOT image
reconstruction (recon) is complex and time-consuming, incompatible with the need for timely clinical decision-
making. This project aims to address these translational barriers by developing and validating a two-pronged
DeepTOBIDx approach that leverages, on the one hand, a seamless integration between high-density DOT and
diagnostic spot compression for lesion-targeted DBT-DOT imaging, and the other, a novel multimodal DNN
model to achieve unprecedented image quality with no human-in-the-loop. From the hardware aspect (Aim 1),
we will engineer a pair of removable optical probes that house more source and detector optodes to achieve
seamless integration of high-density DOT with the DBT spot compression paddle for high-resolution imaging on
targeted lesions. From the image recon aspect (Aim 2), we will develop a novel multimodal DNN to directly map
sensor-domain DOT data to the image domain and further leverage the anatomical DBT to instantaneously
obtain optical images of unprecedented quality. The synthetic-to-real domain adaptation of the DNN model is
adequately addressed by using VICTRE and patient-derived anthropomorphic digital phantoms to represent
complex breast anatomy and lesion characteristics and by adding a realistic noise profile of the imaging system
modeled by a generative adversarial network from real measurements. Finally, in Aim 3, the clinical value of the
DeepTOBIDx approach will be assessed in a rigorously designed blinded multi-reader study on a 210-patient
prospective cohort to determine if the joint interpretation of clinical and DOT images can effectively reduce the
number of unnecessary biopsies. If validated successfully, DeepTOBIDx can facilitate the integration of DOT
with diagnostic mammography in clinical practice and result in direct benefit to breast cancer patients by avoiding
unnecessary procedures and associated burdens. The proposed deep learning-based image recon framework
could also benefit broader clinical applications using other tomographic imaging modalities.

Public health relevance
PROJECT NARRATIVE Integrating tumor function-orientated imaging technology such as near-infrared tomographic optical breast imaging (TOBI) with predominantly structure-oriented clinical diagnostic imaging modalities has demonstrated considerable potential in improving the specificity of breast cancer diagnoses. This project seeks to address the limitation of optical breast imaging in characterizing small lesions by utilizing a deep learning-based image reconstruction framework accompanied by a dual-modal integration with diagnostic x-ray mammography under spot compression (DeepTOBIDx) to achieve marked improvement in optical image resolution, as well as in quantification accuracy and speed. Once validated in the proposed reader study, this work will offer radiologists with actionable lesion functional information to effectively avoid unnecessary biopsies during the diagnostic workup.